In vivo spatiotemporal mapping of genome-wide motions and gene-level transcriptional activity via integrated experimental platform and data-analytical pipeline

Summary:
The human genome is highly dynamic, yet the principles governing its movement are not known. Locally,
chromatin undergoes constant remodeling and rearrangement associated with processes such as
transcription, replication and DNA repair. At large length scales, chromatin dynamics is coherent over microns
and seconds. How the local gene-level processes contribute to nucleus-wide chromatin motions remains an
open question. To address this question, our overall approach is to map spatially and temporally resolved
chromatin dynamics across the nucleus in mammalian cells in vivo, while connecting it with motion and
transcriptional activity of specific genomic loci in real time. To do so, we will develop crosscutting tools
integrating synergistically quantitative approaches derived from the physical sciences with the latest
techniques from molecular biology and biochemistry. We will build an integrated experimental and analytical
platform enabling simultaneous measurements of nucleus-wide and gene-specific motions in real time in vivo
(Aim 1). Specifically, we will establish a data collection and analytical pipeline mapping chromatin motions
across the nucleus in vivo using displacement correlation spectroscopy (DCS), while monitoring motions of
genes visualized by CRISPR/dCas9 technology and tracked via new machine-learning assisted algorithms. In
addition, our platform will monitor the spatiotemporal heterogeneity of chromatin across nucleus and toggle
transcriptional activity of the tracked genes. Using this integrated platform, we will address the fundamental
question of how gene-level transcription activity contributes to genome-wide motions (Aim 2). We will measure
maps of chromatin motions and compaction across the whole genome, while simultaneously determining the
local compaction and mobility of specific genes (MUC4, IL6) as a function of their transcriptional activity. Our
findings will paint a new picture of the complexity and interconnectedness of gene- and genome-level
dynamics and spatial heterogeneity. Finally, we will extend this approach to study interphase chromatin
dynamics and compaction before and after cell differentiation of mouse embryonic stem cells (Aim 3). By
linking gene-level activity to genome-wide compaction and motions, these results will have important
implications for elucidating the role of chromatin dynamics in gene regulation and expression. Moreover, such
knowledge will provide a framework for a mechanistic picture of chromatin dynamics in mammalian cells.

Public health relevance
Narrative: Our aim is to elucidate the connection between the gene-level and genome-wide motions of human genome inside the cell nucleus in live cells in real time. By answering such a fundamental question we will learn new biology and physics underlying the dynamics of the human genome, which is critical for gene regulation, cell homeostasis and healthy development. Such knowledge will lead to a new, mechanistic picture of the dynamic self-organization of the human genome, contributing to current efforts to understand mechanisms of cancer, diabetes and developmental disorders.